DREADD Manipulations of Drug Choice

Project Summary
Cocaine abuse and addiction remain a persistent health problem both in the United States and worldwide. There
are currently no Food and Drug administration-approved pharmacotherapies for cocaine use disorder.
Amphetamine maintenance has shown promise as an effective treatment for cocaine abuse, but abuse liability
and cardiovascular concerns make it unlikely to be approved as a treatment option. Additionally, the mechanism
by which amphetamine functions in this context is unknown; however, amphetamine maintenance has been
shown to blunt cocaine-induced dopamine increases in the nucleus accumbens (NAc). This proposal will
determine the role of mesocorticolimbic dopamine pathway and dopamine tone in modulating cocaine
reinforcement and cocaine-induced increases in mesolimbic dopamine. The premise of this project is that the
mesocorticolimbic VTA dopamine pathway plays a significant role in the modulation of drug seeking behavior.
Aim 1 will determine the effects of stimulatory DREADDs in the VTA on cocaine choice. Male and female TH:Cre
transgenic Sprague-Dawley rats will be virally infected with DREADDs and trained on a cocaine-vs-food choice
procedure. Animals will be chronically administered a DREADD agonist via osmotic pump to activate DREADDs
and determine their effect on cocaine choice. Aim 2 will determine the neurochemical effects of stimulatory and
inhibitory DREADD activation both alone and on cocaine-induced increases in NAc dopamine. Following
recovery from viral infection of DREADDs, animals will be repeatedly administered a DREADD agonist. Basal
NAc dopamine levels and changes in dopaminergic tone following cocaine administration will be measured via
in vivo fiber photometry (e.g. dLight). Overall, this proposal will help improve mechanistic understanding of
cocaine reinforcement and guide development of more effective cocaine use disorder treatments.

Public health relevance
Project Narrative Cocaine abuse and addiction remain a persistent health problem in the United States and worldwide, with no Food and Drug Administration-approved pharmacotherapies for treatment. Amphetamine maintenance has shown promise as an effective pharmacotherapy; however, abuse liability and cardiovascular concerns make amphetamine unlikely to be approved as a treatment option, highlighting the need for preclinical research to elucidate the mechanism underlying the effectiveness of amphetamine maintenance for development of better pharmacotherapies. This application proposes preclinical research using Designer Receptors Exclusively Activated by Designer Drugs (DREADDs) to evaluate the contributions of dopamine to amphetamine maintenance-induced decreases in cocaine self-administration in male and female rats.